Michigan Program for Advancing Cultural Transformation (M-PACT) in Biomedical and Health Sciences

PROJECT SUMMARY: OVERALL
Engaging diverse intellectual capital is imperative for finding creative solutions for complex problems at the
frontiers of biomedical science. As a large public institution, the University of Michigan (UM) has been deeply
involved in both the science and practice of diversity-building. Identifying targets for intervention to promote the
careers of NIH-funded researchers has been a key scholarly focus of PI Reshma Jagsi, who has led national
programs to promote the vitality of the biomedical research workforce. Promoting cross-institutional change in
the service of inclusive excellence at UM has been led for the past 8 years by PI Robert Sellers, UM's first
Chief Diversity Officer. Together with innovative leaders across our campus, we now propose to establish the
Michigan Program for Advancing Cultural Transformation (M-PACT) to consolidate our gains and deepen our
commitment to expanding and sustaining diversity in the biomedical and health sciences. M-PACT will build on
UM's successful Collegiate Fellows Program, a fellows-to-faculty pipeline designed by Co-I Tabbye Chavous,
UM's new Chief Diversity Officer; since its inception, that program has successfully recruited 45 new tenure-
track faculty with demonstrated commitments to diversity, equity and inclusion (DEI). M-PACT will broaden the
reach of this robust pilot program by expanding from one unit to 11 biomedical and health science units across
campus, and address an institutional gap, i.e., recruiting a critical mass of faculty committed to DEI, which is
needed for sustained impact. M-PACT's Administrative Core will oversee the recruitment of 30 new tenure-
track early-career investigators in 3 research clusters that span the breadth of NIH's mission: 1) Basic
Biomedical Research; 2) Clinical-Translational Research; and 3) Social and Behavioral Research. M-PACT's
Faculty Development (FD) Core will train a pool of accomplished Sponsor-Mentors with commitment to DEI
who will serve the M-PACT Scholars and transform culture by seeding change in departments across campus.
The FD Core will implement evidence-based practices, including training to support career development and
networking and culturally aware coaching support to develop the skills of Scholars to succeed in research, find
satisfaction in their professional and community/residential lives and develop into leaders who can sustain the
transformed culture. M-PACT's Evaluation Core will rigorously assess this process and outcomes to inform and
refine the program and disseminate generally. We anticipate that M-PACT will improve the productivity, career
trajectories and experiences of M-PACT Scholars and help transform the broader DEI climate through an
innovative approach that includes deep training of embedded Sponsor-Mentors, Scholars and unit-level
mentors and leaders positioned to affect the experiences of faculty and learners well beyond the Scholars
alone. Buy-in from across the highest levels of central administration, decanal support from the 11 participating
schools/colleges/institutes and close involvement of department leaders will foster institutionalization of best
practices and policies to ensure long-term cultural change.

Public health relevance
PROJECT NARRATIVE: OVERALL The Michigan Program for Advancing Cultural Transformation (M-PACT) in the Biomedical and Health Sciences at the University of Michigan will hire 30 new tenure-track assistant professors into three interdisciplinary research clusters: Basic Biomedical Research; Clinical-Translational Research; and Social and Behavioral Research. M-PACT will harness existing infrastructure and resources, new institutional investments in training and development, and world-class research expertise and mentorship to nurture these early-career faculty for success as independent investigators and to build a sustainable scientific community that is diverse, equitable, inclusive and welcoming.